Training Program in Immunology and Pathogenesis

This renewal application requests continued funding for years 31-35 of a successful,
longstanding program for predoctoral training in Immunology and Pathogenesis. Four
predoctoral positions are requested. Trainees are typically supported for 2 years, allowing for
approximately 12 trainees. The goal of the training program is to prepare trainees for productive
careers in academia, industry, or other science-related occupations. The Training Faculty are
experienced researchers drawn from multiple departments across the Institution including
Microbiology and Immunology, Biology, Biochemistry, Pathology, Surgery, and Regenerative
Medicine. The Training Faculty possess a broad array of expertise while sharing a strong focus
on immunology and pathogenesis. This T32 Program in Immunology and Pathogenesis has
clear strengths that enhance predoctoral training, including: 1) innovative mechanisms such as
the Career Development Workshops, Chalk Talks, Training in Communicating Science to the
Public, and Opportunities for Community Engagement which enhance and add value to
graduate training above that which is normally found in a graduate program, 2) a diverse
training faculty which draws from a number of research programs throughout the Institution, and
3) a history of success in the recruitment of URM students. The success of the Training
Program is evidenced by a very strong publication record and multiple meeting presentations by
the Trainees. Finally, students move on to high quality postdoctoral and career positions
following their training.

Public health relevance
This renewal application requests funds to continue a predoctoral Program for graduate training in Immunology and Pathogenesis. The goal of this long standing Program is to provide value added training to prepare students for productive careers in academia, industry, or other science-related careers.